Streamlining sample preparation with high throughput SpinEx (Separation processing integration for Extracellular vesicles)

Extracellular vesicles (EVs) have emerged as a promising analyte to gain molecular insights into tumors
through minimally invasive and repeated liquid biopsy. EVs carry a repertoire of biomolecules (e.g., proteins,
nucleic acids) from their parent cells. Analyzing these markers offers a unique window into the dynamic status
of tumors. Roadblock to clinical EV assays. Translating EVs into reliable clinical tests faces a signiﬁcant
technical hurdle: sample preparation. EVs exist within highly heterogeneous matrices, necessitating extensive
sample puriﬁcation for accurate downstream analyses. This need is particularly pronounced in blood, the
predominant specimen type. Blood plasma contains various nanoscale vesicles, with lipoprotein particles
(LPPs) outnumbering EVs by over a million times. Compounding this challenge is the similarity in sizes and
densities between LPPs and EVs, making EV puriﬁcation a formidable task. Conventional laboratory methods
(e.g., ultracentrifugation, size-exclusion chromatography) are time-consuming and susceptible to co-isolating
abundant LPPs with EVs. Although new microﬂuidic devices show promise in enhancing EV separation purity,
their complexity and limited throughput have restricted widespread adoption in clinics. Innovations. This
project aims to overcome these challenges by advancing a SpinEx (Separation-processing integration for
Extracellular vesicles) technology. SpinEx is built on two core concepts: dual-mode chromatography (DMC)
and disc ﬂuidics. i) DMC leverages size and surface charge properties to selectively enrich EVs from plasma
while eliminating LPPs. ii) Disc-based ﬂuidics facilitate rapid, high-throughput ﬂow operations with adaptable
ﬂow control by regulating disc spinning. Our pilot study successfully implemented DMC in a disc device and
demonstrated efﬁcient EV isolation. These breakthroughs inspire us to develop a fully automated,
multifunctional SpinEx platform. In Aim 1, we will implement a SpinEx disc and a spinner system. We will
design interchangeable ﬂuidic modules for the disc unit, each dedicated to a speciﬁc task (EV isolation, protein
labeling, RNA extraction). Users can customize workﬂows by "plugging and playing" these modules onto a disc
frame. The spinner system will integrate a speed-controlled motor to rotate a disc and a mechanical arm
designed to actuate ﬂuidic valves within a disc. The developed SpinEx will undergo rigorous performance
evaluation (e.g., EV purity, marker expression, reproducibility) and comparison with standard laboratory
methods. In Aim 2, we will apply SpinEx to process clinical plasma samples for ovarian cancer diagnostics.
SpinEx will isolate EVs and ﬂuorescently label them for target protein detection. This aim will assess SpinEx's
compatibility with real-world clinical samples. Impact. SpinEx's capabilities in rapid EV enrichment, high
throughput, and modular functionality offer transformative potential in establishing robust clinical EV assays.
This advancement could empower large-scale clinical studies on cancer biomarkers and democratize EV
testing for improved early cancer detection and equitable care delivery.

Public health relevance
NARRATIVE We will develop a high-throughput, automated technology to handle clinical bioﬂuids, with the primary objective of facilitating the molecular analysis of extracellular vesicles (EVs). This innovative platform, named SpinEx (Separation-processing integration for Extracellular vesicles), will incorporate a disc-type cartridge to concentrate EVs and prepare them for subsequent analysis (proteins or nucleic acids). We will rigorously evaluate SpinEx's performance by processing both preclinical and clinical ovarian cancer samples.